Investigating epigenetic mechanisms in Down syndrome using human cellular models

SUMMARY
Down syndrome (DS), driven by an extra copy of chromosome 21 (HSA21), is associated with a broad
spectrum of neurological and non-neurological phenotypes, profound interindividual variation and significant
changes in genome-wide gene expression and DNA methylation patterns, although underlying mechanisms
remain incompletely resolved. Epigenetic re-wiring is a promising candidate for achieving the types of genome-
wide changes that are observed in DS as well as contributing to interindividual variation in disease phenotypes.
However, this area of investigation, particularly at the level of chromatin states, remains almost entirely
unexplored in DS. Leveraging human induced pluripotent stem cell (iPSC) models, we recently conducted a
novel, unbiased, and comprehensive survey of the relative abundance of over 80 different histone post-
translational modifications (PTMs) in DS versus euploid controls using histone mass spectrometry. These
results, coupled with additional validation experiments, revealed a set of novel disruptions to H3K36me2,
H3K4me1 and H3K23ac abundance which we predict contribute to DS disease biology. In this proposal, we
aim to expand our analyses to obtain, for the first time, a comprehensive view of how trisomy 21 disrupts
histone PTMs and the downstream impacts on molecular and cellular function. Importantly, this proposal
moves away from a HSA21/gene-centric view of DS, traditionally studied using murine models, to explore how
epigenetic re-wiring may intersect with a set of key unanswered questions in the field using physiologically
relevant human cellular models. Conceptually, our experiments are designed to explore questions around the
significant changes in dosage of genes encoded on euploid chromosomes, the profound interindividual
variation in DS, how different cell types may be impacted by trisomy 21 in divergent or convergent ways, and
how DS mechanisms may overlap with other diseases. Specifically, in Aim I, we will systematically define the
scope of histone PTM abundance phenotypes in DS using a cohort of different donor individuals and cell types
to analyze interindividual and cell-type variation, and then connect these changes to chromatin binding and
transcriptional output for select modifications to elucidate fundamental mechanisms. In Aim II, we will test the
molecular reversibility of histone phenotypes in DS using pharmacological and CRISPRa approaches to
identify potential clinically relevant targets in DS. In Aim III, we will test the hypothesis that dysregulation of
histone PTMs drives core neurobiological phenotypes in DS to further understand their functional relevance
and potentially map known cellular phenotypes to novel molecular mechanisms. Collectively, the rigorous and
innovative analyses in this Transformative Research Award application will illuminate new mechanisms of
epigenetic dysregulation in DS, explore a set of key unanswered questions in the field and may ultimately
inform on therapeutic strategies for DS patients.

Public health relevance
PROJECT NARRATIVE This project uses human induced pluripotent stem cell (iPSC) models to investigate the novel hypothesis that dysregulation of histone modifications in Down syndrome (DS) drives downstream molecular and cellular phenotypes. In addition to elucidating fundamental mechanisms of epigenetic re-wiring in DS, this project will explore a set of key unanswered questions in the field, and test the utility of epigenetic modifiers for normalizing histone phenotypes which has the exiting potential to illuminate new therapeutic targets.